Squirrel Monkey Breeding and Research Resource - Administrative Supplement (Nehete NKT Cell Activation)

Project Summary
Extensive evidence suggests that dysregulation of innate immunity plays a key role in AD pathogenesis. It has
been increasingly acknowledged that tightly regulated stimulation of innate immunity processes and specific
microglia/macrophage activation can be neuroprotective depending on the stimulus and the environment. Toll-
like receptors (TLRs) are a family of innate immune regulators known to play an important role in governing the
phenotypic status of microglia. Major drawbacks of current immunotherapeutic approaches, including the
recently FDA-approved aducanumab, are limited effectiveness against CAA and increased incidence of CAA-
linked complications, such as amyloid-related imaging abnormalities (ARIA). CAA, for which there is no
treatment, is present in nearly all AD cases and promotes rapid cognitive decline. Our initial data using a more
proximate non-human primate (NHP) model of sporadic AD amyloid pathology, squirrel monkey (SQM), which
develops abundant CAA in all aged animals (unlike other primates), indicates that treatment with CpG ODN
Class C safely ameliorates CAA while promoting cognitive benefits. This proposal tackles a new perspective of
innate immunity of Natural Killer T (NKT) cells in squirrel monkey. This project is significant because it is the
first in the field to study the mechanism of NKT cell mediated activation of innate immune cells in squirrel
monkey. Proposed studies will investigate the molecular mechanisms of delivery the synthetic lipid α-GalCer to
activation of NKT leading progressively enhancing innate/adaptive immune responses in cytokines production
and DC activation. Data generated from the proposed studies in squirrel monkey model will form the basis for
designing molecular mechanism-driven innovative strategies to garner the adjuvant potential of NKT cells
approaches with clinical utility to Alzheimer’s disease (AD). The successful completion of this project will
enable us to test the novel concept of immunomodulation in primate models, a critical step before studies in
human clinical trials.

Public health relevance
Projective Narrative Alzheimer’s disease (AD) and age-associated neurodegenerative disorders are major public health concerns and the proposed studies aim to further develop squirrel monkeys as a model species for studies on cognitive aging and their potential associations with neurological and pathological changes in the central nervous system. Natural killer T (NKT) cells are a unique subset of T lymphocytes with the expression of T cell receptor (TCR) and NK cell lineage receptors that can rapidly release large quantities of cytokines and function as a bridge between innate and adaptive immunity. In this proposal we will investigate the involvement of NKT cells in neurological diseases and discuss immunotherapeutic potential.